Core A: Gastric Histopathology

Core A Summary
The primary mission of the Gastric Histopathology Core is to provide high quality, rapid-turnaround specialized
research histology services, including immunohistochemistry, to investigators in this PPG, and to provide
expert histopathologic interpretation, through collaboration with Dr. M. Blanca Piazuelo and Dr. Kay
Washington. The following services are proposed:
1. To provide expert evaluation of histopathology of rodent models of H. pylori-induced gastric neoplasia
and correlation with human disease
2. To provide expertise in developing, performing and evaluating immunohistochemical studies and other
special staining techniques on animal and human tissues, with robust quality control measures, and
with extension to gastroids, as needed
3. To provide tissue microarray services and access to human gastric tissue samples with pathological
annotation and clinical outcome.
The three component projects and Core B (Proteomics and Metabolomics Core) of this proposed Program
Project all rely heavily upon morphologic analysis of gastric tissues isolated from rodent models of Helicobacter
pylori-induced gastritis and gastric neoplasia Core A will coordinate tissue annotation for imaging mass
spectrometry and will use IHC to localize protein targets identified by Core B. Dr. Piazuelo's and Dr.
Washington's expertise in interpretation of histopathologic changes in rodent models and in interpretation of
immunohistochemical studies will be critical to this work, and these collaborative activities are currently not
funded through existing resources. By utilizing the resources of a GI research-related immunohistochemistry
facility, it will be possible to achieve high standards for all histologic studies proposed in this grant. This
centralization of histologic services under the supervision of experienced pathologists with a dedicated interest
in gastrointestinal pathology will allow careful attention to quality assurance.
!

Public health relevance
Core A Narrative The work in this Core will help identify factors important in gastric carcinogenesis through the use of specialized histology services. This may help identify persons at high risk for gastric cancer who can then be treated for H. pylori. !